Cellular commitment to mortality: analyses of mouse early embryo

We carried out DNA microarray-based global expression profiling of all preimplantation stages in mice. It revealed and characterized the distinctive patterns of maternal RNA degradation and two major transient waves of de novo transcription: zygotic genome activation (ZGA) and mid-preimplantation gene activation (MGA). We also developed a technique to do large-scale Whole Mount In Situ Hybridization (WISH), which allows us to reveal the spatial expression patterns of 91 genes in mouse preimplantation embryos. Through these analyses, we identified a number of genes that show unique expression patterns. We have demonstrated that one of them, named Zscan4, is expressed exclusively in 2-cell mouse embryos and ES cells and plays a critical role in the progression of preimplantation development. We also identified genes, named Trim43a, Trim43b, and Trim43c, whose expression began at the 2-cell stage, peaked at the 8-cell/morula stage, and dramatically fell by the blastocyst stage. We are currently investigating whether Zscan4 overexpression can increase the developmental potency of early embryos by injecting Zscan4-manipulated ES cells into mouse blastocysts. We are also studying the effect of Zscan4 on the longevity of mice.